Enhancement of California's Integrated Food Safety and Security System: Discipline B Track 2

Project Summary/Abstract: Discipline B Chemistry, Track 2 FDA LFFM (U19), FOA PAR-20-105 One primary focus of the Food and Drug Laboratory Branch (FDLB) Chemistry Section is the monitoring of food and drug products to ensure a safe supply for public consumption. The primary objective of the human food product testing project is to improve and expand the surveillance testing capacity and capabilities of California's human food products for chemical contaminants and adulterants to support the regulatory agencies in identifying adulterated food items and conducting investigations. We propose to expand and improve chemical testing capacity in the analyses of inorganic and organic contaminants on different food matrices that should cover a variety of food commodities such as fresh produce (vegetables and fruits), manufactured beverages (juice, bottled water, and alcoholic drinks, etc.), milk and related dairy products, baby foods, spices, and seafoods, etc. We will work with FDA and our State food regulatory agency to identify commodity / hazard pairs, and conduct complete studies consisting of large sample counts for each identified pair. To accomplish the goals, we will maintain a well-trained staff who are proficient in all the major analytical methods such as the GC-MS / LC-MS for organic compounds and ICP-MS (EAM 4.7, EAM 4.10, EAM 4.11, EPA 200.8) for metals and speciation analyses, and other technologies such as XRF and ELISA. Recently we have purchased and are acquiring some new instruments to be used in this project, such as LC-QTOF, ICP-MS, and LC-TripleQuad.

Public health relevance
Project Narrative: Discipline B Chemistry, Track 2 FDA LFFM (U19), FOA PAR-20-105 The proposed human food product testing project that will be performed and maintained within California Department of Public Health, Food and Drug Laboratory Branch will greatly improve and expand the surveillance testing capacity and capabilities of California's human and animal food products for chemical contaminants and adulterants to support the regulatory agencies in identifying adulterated food items and conducting investigations. The sample matrices should cover a variety of food commodities, and we will work with FDA and State food regulatory agency to determine commodity/analytes pairs and sampling plan to generate large quantity of data. The project will employ the following major analytical techniques for the analyses of organic contaminants such as selected pesticides, mycotoxins, drug residues, preservatives, seafood toxins such as domoic acid, saxitoxin, okadaic acid, and histamine, and toxic metals: HPLC-DAD, LC/MS/MS, GC/MS, (LC)-ICP-MS. Analytical methods from different sources will be adopted and validated in the laboratory, for example, European Union methods, AOAC methods, FDA methods, EPA methods, and in-house methods.